Biochemical characterization of a novel Fragile X Mental Retardation Protein nuclease function

Project Summary
Fragile X mental retardation syndrome is the most common form of inherited mental impairement, affecting ~ 1
in 4000 males and ~ 1 in 6000 females. The syndrome is caused by the loss of a normal cellular protein, named
the fragile X mental retardation protein (FMRP), which is an RNA binding protein involved in the transport and
translation regulation of specific messenger RNA (mRNA) targets. We have determined that FMRP has nuclease
activity, being able to process precursor microRNAs (pre-miRNAs), potentially being involved in the mature
miRNA biogenesis. The parental proposal, which will characterize this novel FMRP function, has the following
specific aims:
AIM I. Identification of the FMRP domain(s) responsible for its nuclease activity. Under this aim we will
determine: (i) if the FMRP nuclease activity resides in one of his KH domains and identify the active site residues
responsible for this activity by point mutations; (ii) if FMRP S500D has higher nuclease activity as compared with
unphosphorylated FMRP due different dimerization properties and (iii) if the paralogs FXR1P and FXR2P, which
share with FMRP the KH0, KH1 and KH2 domains, also have nuclease activity.
AIM II. Biochemical characterization of the FMRP nuclease activity. Under this specific aim we will: (i)
determine if FMRP and FMRP S500D cleave pre-miRNAs into mature miRNAs; (ii) determine if they have
additional substrates such as RNA perfect duplex, RNA single strand, RNA G quadruplex, DNA-RNA hybrid
duplex, DNA duplex; (iii) characterize the kinetics of their nuclease activity. Similar experiments will pe performed
to test the nuclease activity of the FMRP paralogs FXR1P and FXR2P.
AIM III. Investigation of the FMRP interactions with the SARS-CoV-2 3’-UTR genome and of the potential
role played by its nuclease activity in this viral system. Under this aim we will investigate if FMRP and FMRP
S500D, as well as FXR1P and FXR2P interact with the SARS-CoV-2 3’-UTR genome, cleaving conserved stem-
loops either to potentially yield viral miRNAs or functioning in the antiviral host response.
Fluorescence spectroscopy will be used in all three specific aims of the parent R15 proposal, with the requested
Fluorolog-QM-75-11-C spectrofluorometer and accessories being essential for the success of the proposed
experiments.

Public health relevance
Project Narrative This is a detailed study which characterizes the novel nuclease function we uncovered for fragile X mental retardation protein (FMRP), whose results have the potential to elucidate new biological functions for the protein. Additionally, by characterizing the FMRP interactions with the SARS-CoV-2 genome RNA, the virus responsive for the current COVID 19 pandemic, this study has the potential to identify new targets for the development of antiviral strategies. The requested Fluorolog-QM-75-11-C spectrofluorometer is essential for the success of the proposed experiments.